The origins of amino acid selectivity in the homologation pathway

PROJECT SUMMARY
The objective of this proposed project is to understand the fundamental mechanisms and functions of enzymes
that catalyze homologation (insertion of a methylene group) of an amino acid side chain in natural product (NP)
biosynthesis. The homologation pathway is proposed to be comprised of four enzymes, one known and three
novel ones, and has a narrow substrate scope. The project is focused on determining the origins of substrate
specificity in the pathway for L-Phe and L-Tyr homologation in the biosynthesis of cyanobacterium NPs
anabaenopeptins. The following Aims are designed to achieve this objective: Aim 1: determination of the origins
of specificity (among novel enzymes, HphA, HphB, or HphCD) in the homologation pathway of L-Phe and L-Tyr
and Aim 2: rational homology-based mutagenesis to alter the substrate scope of specific homologation
enzyme(s) and determination of crystal structure of these enzymes. By biochemical characterization of each
enzyme in Aim 1a and establishment of the substrate profile in Aim 1b, the enzyme(s) contributing to the
specificity of homologation will be identified. The substrate selective enzyme(s) will be mutated to alter or expand
the substrate scope of the enzyme(s) so that nonproteinogenic or other proteinogenic amino acids can be
homologated in Aim 2a. These enzymes will be characterized structurally by X-ray crystallography to further
guide the mutagenesis studies in Aim 2b. NPs are one of the major sources of biological probes and medicines.
Modification of known bioactive compounds is a cost- and time-effective way to discover and expand the
chemical diversity of bioactive compounds to alter or improve their properties. However, the complex structure
of NPs makes the specific modification of the molecules by organic chemistry challenging. Therefore,
combinatorial biosynthesis that uses the recombinant biosynthetic pathway to produce “unnatural” natural
products is highly attractive. Homologation of amino acid moieties is a rare modification in peptide NPs, termed
nonribosomal peptides (NRPs) which are one of the major targets of NP engineering due to the flexibility of their
biosynthetic pathways. Since this modification is observed only in cyanobacterial and fungal species, it has great
potential to derivatize NRPs produced by these and other species, which has never been performed. The
knowledge gained by this project will ultimately lead to an enzymatic and genetic tool that can derivatize a variety
of NPs.

Public health relevance
PROJECT NARRATIVE The proposed research investigates the poorly understood biochemical process, homologation, in natural product biosynthesis. Homologation has the potential to provide additional benefits to bioactive molecules. The knowledge gained in this project is expected to be widely applicable for natural product research to create new drugs and drug leads.